ASEHL Admin Core

ASEHL Project Summary-Admin SFY21-25 The Alaska State Environmental Health Laboratory (ASEHL) has sufficient personnel, experience, and authority to manage activities to complete these projects. The administrative documentation and actions include: supervisory, resource management, expenditure and procurement approval, coding instruction for personnel time, workload prioritization, general coordination, routine IT support, financial review, administrative reports, coordination with sampling agency, in-state travel approvals, and attendance at required and facultative meetings and conferences. This includes quarterly reports, mid- year progress report, and RPPR. By maintaining and enhancing ISO/IEC 17025 for food testing, the Alaska State Environmental Health Laboratory (ASEHL) will continue to deliver both scientifically valid and legally defensible data to its clients. The clients, including the Alaska Food Safety and Sanitation (FSS) Program and U.S. FDA, will benefit by receiving enhanced customer service, consistent turnaround times, and little to no down time. Accreditation allows ASEHL to satisfy Standard 10 of the Manufactured Food Regulatory Program Standards (MFRPS) as the primary designated testing facility for the Food Safety and Sanitation Program (FSS). FSS is in full conformance to MRFPS standards.